Scientific Core

ANALYTICAL AND BIOCHEMICAL CORE (CORE B) ABSTRACT
The overall goal of the biochemical synthesis and analytical core (Core B) will be to provide state-of-the-art
measurements of isolevuglandins (isoLGs) and related lipid metabolites, provide IsoLGs for participants of the
PPG and use state of the art high energy mass spectroscopy to define specific peptides that are IsoLG
adducted. Core B will analyze the amount of IsoLG-lysyl protein adducts (IsoLG-Lys) in cells and tissues of
both experimental animals (projects 1, 2 and 4) and in cells and plasma of human subjects (all projects).
Because IsoLGs so rapidly react with lysine residues of proteins, unreacted IsoLG cannot be measured in
biological systems. Thus, for overall quantification of IsoLGs in cells and tissues we quantify IsoLG-lys. Core B
is also perfecting high energy mass spectroscopy to define specific peptides and proteins adducted by IsoLG
and will use this to detect specific targets of IsoLG adduction in humans and experimental models. A second
approach for detection and quantification of IsoLG adducts will involve the use of the single chain antibody D-
11, which detects IsoLG adducted to proteins and peptides, independent of the peptide backbone. When
needed, core B will provide PPG investigators with fluorescently tagged D-11 for use in flow cytometry and
immunostaining. Core B will also synthesize IsoLG active analogs including alkynyl-IsoLG, and the inactive
synthetic precursor of IsoLG, IsoLG-dimethoxyacetal (IsoLG-DMA) and anhydro-IsoLG for use in cultured cells
and experimental animals. Core B will measure levels of 2-hydroxybenzylaime in plasma and tissues from both
experimental animals and plasma of humans in all projects. The methods and reagents provided by Core B are
highly unique, and have been developed by the Core Director, Dr. Davies and other Project investigators
during the past decade. It is essential that the Project Directors have access to these resources for successful
completion of the PPG.